Mentoring in Musculoskeletal Pain Phenotypes

PROJECT SUMMARY/ ABSTRACT This is a submission for a Midcareer Investigator Award in Patient-Oriented
Research (K24). The applicant, Dr. Adam Goode, is a clinician-scientist and Associate Professor in the Duke University
Department of Orthopedic Surgery. Throughout his career, Dr. Goode has worked on epidemiological and mechanistic
studies to better understand the heterogeneity that exists with low back pain and musculoskeletal conditions. These studies
use advanced imaging and biochemical biomarkers found in serum and urine to characterize disease status and
progression. These efforts have resulted in a current R01 Mechanical Biomarkers of Chronic Low Back Pain (AR075399)
on advanced imaging of the intervertebral disc to characterize the role of mechanical strain with low back pain and a
recently funded R01 Biological and Biomechanical Predictors of Cartilage Health Following Meniscus Injury
(AR079184). These activities and projects engage a broad multidisciplinary team focused on advancing our understanding
of low back pain, spine and knee OA in patient oriented research. The current application requests funding (50% salary
support) for 5 years to support the protected time necessary to conduct the proposed patient oriented research and to
expand opportunities for mentoring within the Duke University. This protected time will allow Dr. Goode to continue to
lead a productive research group and maintain minimal teaching and administrative responsibility at the Departmental and
University levels. As part of this application Dr. Goode will advance his epidemiological and mechanistic expertise by
combining these areas with incorporating real world data to understand the health care utilization along with the transition
from acute to chronic low back pain. There are plentiful opportunities to expand the work Dr. Goode has begun, and
extremely high potential for clinical break-through in this important area of clinical research.

Public health relevance
PROJECT NARRATIVE: Chronic musculoskeletal conditions, such as low back pain, have substantial costs and burden on society. A better understanding of the underlying reason for developing chronic low back pain is needed. This award will allow the PI to expand his mentoring of trainees in musculoskeletal pain phenotypes and leverage the rich clinical research environment at Duke University to advance his current clinic research.